Targeting tumor and T cell DNA methylomes to improve CAR T cell therapies for diffuse midline glioma

SUMMARY/ABSTRACT
While improvements in immune therapies have revolutionized treatments in some cancers, pediatric brain tumors
are especially resistant to current immunotherapy treatments, including immune check point inhibitors. This may
be because many pediatric brain tumors have been characterized as “immune cold”, with little to no immune cell
infiltration. Chimeric antigen receptor (CAR) T cell therapies have shown promise against fatal brain tumors such
as diffuse midline glioma (DMG) in early clinical studies. However, in early studies, patients inevitably succumb
to this fatal disease. This raises important questions about mechanisms of CAR T cell resistance and devising
strategies to improve and prolong CAR T cell function. Targeting epigenetic programs has been identified as one
strategy to overcome deficient immune responses in solid tumors through both tumor cell intrinsic and tumor
microenvironment mechanisms. We have shown in DMG that inhibition of DNA methylation activates innate
immune pathways that may stimulate immune cell recruitment and activity (Krug et al., Cancer Cell, 2019). Our
data in CAR T cells deficient for a DNA methyl transferase (DNMT3A) displays reduced exhaustion and
enhanced anti-tumor activity against multiple tumor models, including brain tumors (Prinzing et al., Science
Translational Medicine, 2021). We hypothesize that combinatorial approaches that target distinct DMG and
CAR T cell DNA methylomes represents a rational strategy to enhance CAR T cell therapy. We propose to test
this in two specific aims: AIM1: Determine how tumor DNA demethylation in DMG impacts CAR T cell recruitment
and function. We will test the hypothesis that inhibition of DNA methylation induced endogenous retroviral
activation will enhance CART cell activation and persistence. AIM2: Determine if CAR T cell effector function is
improved by DNA methylation inhibition in DMG. We will test the hypothesis that inhibition of DNA methylation
in CAR T cells is a phenotype that translates to DMG, by preventing T cell exhaustion and improving long-term
effector function.

Public health relevance
NARRATIVE The overall goal of this proposal is to evaluate the impact of DNA methylation inhibition of tumor cells, CAR T cells, and combined towards more effective treatments against diffuse midline glioma. Our secondary goal is to understand the treatment naïve microenvironment in DMG and how this environment changes in response to DNA methylation inhibition and CAR T cell administration. Our studies may pave the way for more effective treatments against DMG, a universally fatal disease with limited treatment options.